High throughput assessment of de novo CNV formation in eukaryotic cells

DESCRIPTION (provided by applicant): PROJECT SUMMARY Copy number variants (CNVs) - submicroscopic chromosomal deletions or duplications of 50 base pairs to more than a megabase - are a critical component of human genetic variation in both health and disease. Tens of thousands of CNVs are recognized in the human population across all chromosomes. Humans differ at many CNV sites, typically >100 per individual. Because of their size, CNVs often affect gene content and are thus an important contributor to diversity. CNVs have a high de novo mutation rate, with an estimated 1-3% of individuals bearing an allele not present in either parent. Consistently, CNVs are a common mutation in genetic disorders, including intellectual disability, neuropsychiatric disorders, structural birth defects and others, as well as cancer in the form of somatic mutations. Identifying the genetic and environmental factors that determine an individual's risk of forming new CNVs requires that candidate factors be assessed in prospective, hypothesis- driven and controlled experiments. We developed a human in vitro cell system that allows scoring of de novo CNV formation genome-wide in an experimental setting through application of microarrays and/or mate-pair sequencing to manipulated cell clones. This approach demonstrated that two mechanistically distinct replication inhibitors induce CNVs in cell culture, suggesting that any condition that leads to replication stress might induce deleterious CNVs. Many further candidate environmental and genetic CNV risk factors must be studied in this hypothesis-testing approach, but the slow, laborious and expensive nature of current methods has impeded rapid and extensive expanded application. The purpose of this project is to develop improved and rapid methods for experimental CNV detection, which will be achieved by exploiting knowledge gained from prior efforts. Rationally designed assays will be created and compared that have a restricted focus on hotspots of increased CNV formation. In Aim 1, an in-depth comparison of human fibroblasts and lymphoblastoid cells will be performed with respect to the location of CNV hotspots and their association with fragile sites and transcription units. This will yield a se of characterized hotspots broadly informative to all human CNV formation. In Aim 2, a series of innovative approaches for high throughput CNV detection will be developed and their utility compared for experimental and screening applications. Optimized tools will be used in future studies to elucidate the mechanisms of CNV formation and how these are modulated by environmental stresses.

Public health relevance
PUBLIC HEALTH RELEVANCE: PROJECT NARRATIVE Copy number variants (CNVs) - submicroscopic chromosomal deletions or duplications of 50 base pairs to more than a megabase - are a critical component of human genetic variation in health and disease. Identifying the genetic and environmental factors that determine the risk of forming new CNVs requires that candidate factors be assessed in controlled experiments. The project will develop improved methods for experimental CNV detection through a rational approach directed at hotspots of increased CNV formation and use these new assays to test specific hypotheses regarding CNV risk factors. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Copy number variants (CNVs) - defined as submicroscopic chromosomal deletions or duplications of 50 base pairs to more than a megabase - are a critical component of human genetic variation in both health and disease. From extensive descriptive genomics efforts we know that CNVs are widely distributed throughout the genome, with tens of thousands in the human population across all chromosomes [6,7]. Humans all possess, and differ at, many CNV sites, typically >100 per individual [7-9]. Over 10% of polymorphic CNVs intersect with genes and are thus an important contributor to phenotypic diversity [7]. Equally strikingly, CNVs have a high de novo mutation rate, with an estimated 1-3% of individuals bearing an allele not present in either parent [9,10]. Consistently, CNVs are an important class of mutation in genetic disorders, including intellectual disability, neuropsychiatric disorders, structural birth defects and others [11,12]. Finally, CNVs and related chromosome anomalies occur at a high rate in somatic cells in the development of malignancy [13-15]. Genetic and environmental factors almost certainly increase the risk for formation of new CNVs, but there is little information on this important topic. Addressing this need requires that candidate risk factors be assessed in prospective, hypothesis-driven and controlled experiments, which is not the forte of hypothesis- generating descriptive genomics approaches. To this end, we developed a human in vitro cell system that allows unbiased, genome-wide scoring of de novo CNV formation in an experimental setting through application of microarrays [1,16] and mate-pair sequencing [17] to manipulated cell clones. This approach allowed us to test a main hypotheses generated by descriptive studies: that many CNVs arise through mishandling of problems at replication forks. We demonstrated that two mechanistically distinct replication inhibitors, the DNA polymerase inhibitor aphidicolin (APH) and pharmacologically relevant doses of the ribonucleotide reductase inhibitor hydroxyurea (HU), readily induce CNVs in culture [1,16]. The size and nonhomologous junction structure of induced CNVs were highly similar to each other and to many human polymorphic and pathogenic CNVs, suggesting that any condition that leads to "replication stress" might induce deleterious CNVs. More recently, we showed that the nonhomologous end-joining (NHEJ) repair pathway is not required for CNV formation [18]. Many additional candidate environmental and genetic CNV risk factors should be studied in this hypothesis-testing experimental approach. However, the slow, laborious and expensive nature of the current method has impeded its rapid and extensive expanded application. The purpose of this R21 is to develop improved methods for experimental CNV detection. We will achieve this by exploiting skills we have developed and knowledge we have gained in efforts above, putting us in a unique position to conduct these studies. A principle innovation we bring is that while de novo CNVs are distributed throughout the genome, there are "hotspots" of CNV formation that appear to correlate with chromosome fragile sites, regions of low replication origin density [1,19], and, from our newest data, large transcription units. We will exploit this insight by creating rationally designed assays with a restricted focus on CNV hotspots. To ensure that these efforts will have the broadest possible impact, we will first perform experiments designed to generate a highly useful set of CNV hotspots with several types of correlative information collected in distinct cell types. Aim #1: Establish highly informative panels of CNV hotspots. We have in hand a comprehensive microarray-generated panel of CNVs and hotspots in a fibroblast cell line, as well as a genome-wide mapping of transcription units from nascent RNA-Seq. We will use these same approaches to establish the induced CNV and transcription profiles of a lymphoblastoid line, a cell type well-characterized for chromosome fragile sites. Results will provide a highly informative set of CNV hotspots for use in Aim 2, one stratified with respect to cell-type specificity and association with fragile sites and large transcription units. Aim #2: Develop rationally-designed high-throughput CNV assays. Our use of microarrays is driven by the need for an initially comprehensive and unbiased assessment of genome-wide CNV occurrence, but is inefficient since prolonged cell cloning is required and because we now know that de novo CNVs are non- random in a manner that likely reflects mechanism. We will thus create rationally designed assays in which primers and probes will be directed to a variety of CNV hotspots where assay efficiency is promoted by inherently high event frequencies. Through sensitive techniques such as digital PCR, our ultimate technical objective is to score allelic loss in populations of treated cells. To ensure that structural information can still be obtained, we will also develop novel capture-assisted hotspot sequencing for detecting induced CNVs wherein libraries from pooled cells will be used to score de novo junctions by computational algorithms. We will use the developed assays to compare deletion profiles at target loci in two fibroblast cell lines with known differences in the transcriptional state of CNV hotspots.